CORE--BIOSTATISTICS CORE

The Biostatistics Core provides statistical analyses related to all laboratory experiments and clinical trials, ensuring accurate quantification and interpretation of the results.